Investigating nuclear plasticity in the human placental syncytium

ABSTRACT
During human pregnancy the interface between the maternal and fetal vasculature is a tissue-sized multinucleate
cell termed the syncytiotrophoblast (STB). The STB is essential for transport, fetal immunoprotection, metabolic
functions, and is the primary producer of placenta hormones. Surrounded by maternal blood, the STB must
maintain these diverse functions while responding to extracellular stresses like hypoxia, oxidative stress, and
inflammation to maintain a healthy pregnancy. In fact, systemic STB stress is a key driver of maternal pathology
in preeclampsia, a leading cause of maternal and fetal mortality that affects 5-10% of pregnancies. The objective
of my long-term research program is to dissect how a single giant cell supports these diverse functions while
simultaneously reacting to stress. In fact, my research has revealed that individual nuclei in the STB express
different sets of genes and therefore adopt distinct nuclear subtype identities. These nuclear subtypes shift in
proportion throughout gestation and in response to environmental cues, suggesting the STB can adapt its
distribution of nuclear subtypes to the fluctuating maternal environment. How are unique nuclear subtypes
created and modified in a shared cytoplasm? Ultrastructure analyses of nuclei in the STB reveal diverse sizes,
shapes, and degrees of chromatin compaction, suggesting the transcriptional diversity among STB subtypes
could arise from distinct epigenetic landscapes. Further, I have identified candidate chromatin remodelers and
transcription factors whose expression is specific to individual STB subtypes and could regulate their unique
transcriptional identities. Therefore, I hypothesize that epigenetic regulation facilitates the formation of distinct
nuclear subtypes and drives STB adaptation to stress. My research goals to test these hypotheses are 1-
determine the mechanism of nuclear subtype adaptation during stress and 2- map the unique epigenetic
regulation of each STB nuclear subtype. I will complete this training in Dr. Amy Gladfelter’s lab, a supportive and
inspiring mentor who has ensured I have all resources necessary to achieve the proposed Aims. However, to
obtain my research goals I require additional experimental and intellectual training in lineage tracing and
epigenomic profiling. This will be accomplished with a world-class advisory committee at Duke University. To test
how STB nuclear subtypes adapt to stress, I will work with work with Dr. Purushothama Rao Tata to master
cutting-edge CRISPR lineage tracing experiments. To map the epigenetic regulation of STB nuclear subtypes, I
will work with leaders in cutting-edge chromatin techniques including Dr. Anoop Patel, Dr. David MacAlpine, and
Dr. Greg Wang. This training will lay the groundwork for my independent research program that dissects the
epigenetic mechanisms by which a giant STB cell can support diverse cell functions while adapting to stress.
Ultimately, I aim to use these molecular studies to identify therapeutic targets that mitigate STB stress during
pregnancy disease. This K99/R00 award will enable me build collaborations with experts in plasticity and
epigenomics and master these new fields with focused training, seminars, workshops, and conferences.

Public health relevance
PROJECT NARRATIVE During human pregnancy, the syncytiotrophoblast (STB) is a tissue-sized, single cell that forms the interface between maternal and fetal vasculature and performs many essential functions. Systemic STB stress is a key driver of maternal pathology in preeclampsia, a leading cause of maternal and fetal mortality that affects 5-10% of pregnancies. This proposal aims to understand the molecular mechanisms underlying the STB's stress response, with the long-term goal of identifying therapeutic targets to mitigate STB stress and treat pregnancy disease.